SEX DIFFEFENCES IN B-ADRENERGIC MEDIATED CALCIUM INFLUX

While gender differences in human myocardial responses to stress have been observed, the cellular events mediating these differences are unknown. Myocardial contractile responses to stress are primarily mediated by beta-adrenergic receptor stimulation. Beta-adrenergic receptor activation results in a greater Ca2+ influx (Ca2+ current) through membrane L-type Ca2+ channels. The specific aims of this proposed study are: 1) to determine sex differences in number and properties of L-type Ca2+ channels and 2) to determine sex differences in the basal and isoproterenol-stimulated Ca2+ current. Specific aim 1 will be addressed using protein (Ca2+ channel) binding studies in male and female rat atrial and ventricular membranes. Specific aim 2 will be addressed using whole-cell current recording studies in isolated atrial and ventricular myocytes from male and female rats. The long-term objective of this plan of research is to identify and understand the electrophysiologic basis of human gender differences in beta-adrenergic mediated effects on myocardial contractility. Elucidating electrophysiologic mechanisms mediating these gender differences establishes a physiologic basis for nursing practice in evaluating and treating stress-associated myocardial dysfunctions.